Thrombospondin1-regulated atrophy in the heart

Abstract
Like skeletal muscle myofibers, cardiomyocytes in the heart constantly adjust their size based on
perceived workload or disease stimulation, in which hypertrophic versus atrophic pathways are in
balance to achieve an appropriate equilibrium matched to real-time workloads. In a less
appreciated process, both heart and skeletal muscle can reduce size through molecular
regulatory pathways that cause tissue catabolism. This reduction in size is referred to as atrophy
and this process can underlie tissue remodeling and responses to disease stimulation or loss of
sufficient nutrients (such as starvation) in which both tissues can serve as metabolic reservoirs.
Here we uncovered a novel function for thrombospondin1 as a regulator of both cardiac and
skeletal muscle atrophy. We have previously shown that the thrombospondin gene family (Thbs1-
5) plays a critical role in membrane stability through effects on the ER stress response and
secretory pathways, as well as controlling the integrin and dystrophin-glycoprotein complexes
present with the sarcolemma. However, more recently we have discovered that Thbs1 is uniquely
induced by disease stimuli associated with cardiac remodeling and caloric restriction, and that
Thbs1 uniquely regulates cellular atrophy and autophagy through an intracellular pathway within
the ER/SR that functions at 2 levels. 1) Thbs1 directly binds and regulates the ER stress factor
PERK and eIF2α to mediate cardiomyocyte atrophy through the transcription factor ATF4, and 2)
Thbs1 selectively expands lysosomes and the vesicular pathway of autophagy. Hence, we
hypothesize that Thbs1 is an ER-dependent chaperone that mediates cardiomyocyte size
reduction, in part, by driving the catabolic process through autophagy. To investigate this
hypothesis, we will interrogate 2 specific aims: 1) To examine the mechanisms of cardiac atrophy
and autophagy through PERK/eIF2α/ATF4 signaling mediated by Thbs1 within the ER
compartment. 2) To examine a mechanism whereby cardiac autophagy is mediated by Thbs1-
dependent formation of lysosomes and associated catabolic vesicular activity. The proposed
course of investigation will be conducted in both cultured cardiomyocytes and in genetically
modified mouse models so that both reductionist and mechanistic approaches can be taken, as
well as in vivo assessment in a physiologically relevant context. The proposed application is
innovative as it will define for the first time what appears to be a novel cell biology pathway through
Thbs1 that controls striated muscle remodeling through atrophy and autophagy.

Public health relevance
Narrative The endoplasmic reticulum (ER) stress response appears is a universal feature of all cardiomyopathies as well as healing after cardiac injury or disease initiation. Here we have identified a novel function for thrombospondin1 (Thbs1) as an intracellular regulator of the ER stress response that then leads to enhanced cardiac atrophy thorugh a specific signaling mechanism with the ER and that effects autophagosome formation. Understanding how and why Thbs1 has this unique molecular function is of medical relevance as many forms of heart disease are associated with ventricular remodeling and loss of tissue mass.